VA Video Connect to Improve Access to Multi-disciplinary Specialty Care

Background: Improving retention in human immunodeficiency virus (HIV) care and increasing the proportion
of Veterans with persistent HIV suppression is one of the 4 national priorities outlined in the VHA HIV, Hepatitis
and Related Conditions Program’s 2016 Annual Report. Treatment of complex conditions like HIV requires
multidisciplinary care and monitoring at regular clinic visits with multiple providers. In VHA that care is located
and delivered primarily in VA medical centers, posing logistic and stigma related barriers to Veterans’ access
to multidisciplinary HIV care. VA Video Connect (VVC), a VA-supported mobile health video technology that
allows Veterans and providers to complete clinical visits from any remote location including the home, has the
potential to transform delivery of multidisciplinary care for HIV and other chronic conditions by increasing
access to care. VA leadership wants 5% of Veterans to receive care via VVC in FY2018, but less than 0.1% of
Veterans with HIV have used VVC. VVC could help fill these gaps in care.
Specific Aims: The aims are: Aim 1-Clinical Effectiveness: To determine the effectiveness of VVC-delivered,
multidisciplinary HIV care compared to routine care on retention in care. Aim 2-Implementation: To conduct a
mixed-methods formative evaluation to refine and evaluate our implementation facilitation (IF) strategy to
improve the reach of VVC-delivered HIV care, increase provider and Veteran adoption, and determine potential
for sustainability. Exploratory Aim: To assess the implementation potential of VVC- delivered HIV care across 6
diverse VHA settings and identify contextually specific barriers and facilitators to adoption.
Significance to Veterans’ Health: The VA is one of the largest providers of HIV care in the US, and improving
retention in care and HIV suppression is associated with improved survival with HIV.
Priority areas: Improving access to care, modernization of VA, healthcare equity and health disparities.
Innovation: While VVC is gaining a foothold in mental health care, it has not been widely used in specialty
medical care. We will determine if multidisciplinary care delivered by VVC can improve retention in care and
clinical outcomes for vulnerable Veterans in need of specialty medical care. The research will provide models
and evidence for a transformative solution to increase Veterans' access to multidisciplinary care.
Methodology: Aim 1 will be achieved with a pragmatic, Hybrid Type II effectiveness-implementation study
within the Michael E. DeBakey VA Medical Center infectious diseases clinic, which cares for nearly 1000
Veterans with HIV. We will deploy an IF strategy to facilitate uptake of VVC and randomize Veterans to either
be offered or not offered VVC. The study will enroll 360 Veterans and is powered to detect a 12% absolute
improvement in retention in care, the primary outcome. Secondary outcomes include adherence to
antiretroviral therapy, HIV suppression, and safety measures. Guided by the RE-AIM QuEST framework, Aim 2
layers a mixed-method evaluation on top of the effectiveness trial, enrolling 40 Veteran participants and
numerous staff in in-depth interviews at all phases of the trial. The Exploratory Aim will be conducted working
with 6 diverse VA HIV clinics and includes assessing organizational readiness, deploying the IF strategy,
conducting in-depth interviews, and assessing reach and adoption of VVC in these clinics.
Expected Results: We hypothesize that VVC will improve engagement and clinical outcomes and be
acceptable to patients and providers. We will generate extremely valuable data and experience on
implementation of VVC outside mental health care, regardless of impact on HIV care, and identify IF strategies
that could be used in later implementation of VVC.
Next Steps: If successful, we will work with partners to disseminate and implement VVC for multi-disciplinary
HIV care throughout VA. We will also foster work in other chronic medical conditions. Our results could lead to
accelerated uptake of VVC, improved access to care, and improved health for many Veterans.

Public health relevance
Project Narrative We will impact Veteran’s healthcare by improving on-going access to VA multidisciplinary care services to Veterans with HIV by facilitating the implementation of VA Video Connect (VVC). VVC is a VA-supported mobile health video technology that allows Veterans and providers to complete clinical visits from any remote location including the home. We will test whether we can increase Veterans use of VVC in the HIV clinic in the Houston VA, identify the impact of VVC on the Veterans health, and then conduct work to facilitate implementation in HIV clinics in 6 other VA centers throughout the US. VVC is a disruptive technology that can change the way vulnerable Veterans receive primary care, specialty care, social services, and mental health. This project will provide the evidence needed to expand VVC use and the services using VVC, and will provide critical data on how best to do so. It directly addresses priorities to modernize VA.